Cellular and Molecular Biology at Michigan

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
This application requests support for the new and redesigned Cellular and Molecular Biology Ph.D. Program (CMB) at the University of Michigan (UM). The mission of the CMB program is to train a broad group of scientists to conduct responsible and rigorous research in cellular and molecular biology and to prepare them to be successful in multiple careers in biomedical sciences. To pursue this mission, CMB will use evidence-based methods to train students in discipline-related and transferable skills via an individualized and structured competency-based curriculum, train faculty in effective mentoring practices, and use systematic evaluation and intervention to continuously improve its inclusive training practices. Discipline-related training includes foundational coursework and seminars in cell biology, biochemistry, genetics, and quantitative biology, broad exposure to research via weekly Student Seminars, student-organized Short Courses, an Annual Research Symposium, and an Annual Retreat, deep knowledge of an area via rigorous and reproducible research in mentored dissertation projects, and experiential learning in a wide range of areas in basic and translational biomedical sciences. Training in transferable skills range from competency-based courses (such as on scientific communication) to experiential workshops (such as on leadership) offered at the programmatic and institutional levels. Key new elements include 1) competency mapping to courses with a renewed focus on transferable skills and professional development, 2) structured requirements for training in “Rigor and Reproducibility”, “Responsible Conduct of Research”, and scientific communication, 3) a Guided Actionable Plan for career development, 4) the addition of mentor training for faculty and an individualized mentoring plan for each student as requirements, and 5) the addition of formative evaluation strategies for programming. CMB has strong institutional support from the UM Medical School and from Rackham Graduate School, as well as from individual departments that participate in the program. Faculty in the program are scientifically varied and well-funded, and the program actively and successfully recruits an outstanding group of students from a national pool. Approximately 75% students join via the umbrella Program in Biomedical Sciences (PIBS, covering 13 biomedical Ph.D. programs) and 25% from the Medical Scientist Training Program (MSTP). Modern biomedical science has become increasingly collaborative and team-based, and there is a clear need for researchers with an operational knowledge of a wide range of disciplines while holding deep expertise of their focused discipline. As a long- standing interdisciplinary collaboration between over 20 departments across 4 colleges, CMB is uniquely positioned to fill this need by training new generations of scientists to collaboratively and address fundamental questions in cellular and molecular biology and generate innovative research strategies bridging basic and translational fields to improve human health.

Public health relevance
No Change. Original Text below. The research performed by students in the CMB program addresses fundamental questions about the nation’s pressing public health concerns, including prevalent chronic disorders (e.g., cancer, diabetes, heart disease), neurological conditions (e.g., Alzheimer’s, epilepsy, addiction), and infectious diseases. Training a broad pool of students, using evidence-based approaches that combine broad exposure and focused training of students in cellular and molecular approaches, effective mentor training, and program evaluation at multiple levels, fills a critical need for producing well- trained scientists in the biomedical workforce who work to advance fundamental knowledge in areas relevant to advancing health, reducing illness and improving the quality of human life.